MOTS-C, APOE, and Alzheimer's disease

The 4 allele of apolipoprotein E (APOE4) is associated with accelerated aging and mortality as well as increased
vulnerability to Alzheimer’s disease (AD). Although the causal links between APOE4, aging, and AD risk remain
to be fully defined, candidate mechanisms include regulation of systemic immunometabolic outcomes. Our
recent findings demonstrate that treatment with the novel mitochondrial-derived peptide MOTS-c increases
healthy lifespan. Indeed, pathways identified to be beneficially regulated by MOTS-c overlap with pathways
thought to underlie relationships among APOE4, aging, and AD. In this proposal, we investigate the central
hypothesis that MOTS-c is a geroprotective peptide that targets systemic APOE4 phenotypes implicated
in driving age-related cognitive impairment and AD pathogenesis. We will investigate this hypothesis by
studying systemic and neural effects of MOTS-c across age in mice with human APOE genotypes both in the
absence and presence of AD transgenes and in tau mice. Our studies will interrogate potential mechanisms
hypothesized to underlie the protective actions of MOTS-c with an emphasis on lipid homeostasis and
macrophage reprogramming. We propose three aims that are highly interactive across the labs of the two mPI
labs who have strong expertise in AD and APOE (Dr. Pike) and MOTS-s and geroscience (Dr. Lee). Aim 1:
Does MOTS-c protect against APOE4-associated aging phenotypes? We test the hypothesis that MOTS-c
will improve systemic and neural outcomes in the contexts of aging and APOE4 genotype. Studies will test the
ability of MOTS-c to prevent vs treat APOE4-associated phenotypes. We will also test the prediction that
inhibition of endogenous MOTS-c will exacerbate aging outcomes, especially with APOE4 genotype. Aim 2:
Does MOTS-c treatment provide protection/treatment against Alzheimer pathology in an APOE-
dependent manner? The second aim is conceptually parallel to Aim 1 but with a focus on MOTS-c and APOE
genotype in the context of AD pathology. These studies will be conducted in male and female APOE3 vs APOE4
AD mice and tau mice to determine potential sex differences and at two different ages to consider efficacies for
both the prevention and treatment. As in Aim 1, we will also consider the effects of inhibiting endogenous MOTS-
c. Aim 3: Does MOTS-c reprogram aging APOE4 macrophages/microglia to protect from Alzheimer
pathology? We investigate the hypothesis that a primary mechanism by which MOTS-c protects against APOE4
phenotypes is reprogramming of monocyte-derived macrophages and microglia at both transcriptional and
functional levels. Studies will test whether MOTS-c-programmed macrophages/microglia are poised to clear A
more effectively and resolve inflammatory phenotypes that can impede neuronal homeostasis. Completion of
the proposed studies will yield preclinical data that define the interactions and underlying mechanisms among
MOTS-c, APOE genotype, sex, age, and intervention timing, relationships that are essential to the effective
clinical translation of this novel mitochondrial-derived peptide approach to combat cognitive decline and AD.

Public health relevance
Project Narrative Effective therapies for Alzheimer’s disease (AD) have remained elusive and new research avenues are needed. Candidate interventions with potential impact on AD are emerging from geroscience, including the use of compounds that increase healthspan and longevity. This project aims to understand the therapeutic potential of the protective mitochondrial-derived peptide MOTS-c against APOE genotype- and AD-related impairments, knowledge that could be rapidly translated into approaches to prevent and treat AD.